Dissecting the heterogeneity of oral cancer pain

PROJECT SUMMARY/ABSTRACT
This proposal presents a five-year research career development program focused on the neurobiologic
mechanisms responsible for oral cancer pain. The candidate is a clinician-scientist and is firmly committed to a
career in translational research studying the neurobiology of orofacial pain in pediatric patients. The outlined
proposal builds on the candidate’s previous basic and clinical research skills by integrating patient-oriented
translational research. Under the mentorship of Dr. Brian Schmidt at New York University, the candidate will
have the opportunity to work with a research program that defined the clinical phenotype of a painful orofacial
condition, and developed a paradigm that allows investigators to test nociceptive mechanisms responsible for
the phenotypic features of the painful condition. The proposed research and career development plan will
position the candidate with a unique set of cross disciplinary skills that will enable her transition to independence
as a translational scientist focused on the clinical management of orofacial pain in pediatric patients.
The incidence of oral cancer is rapidly increasing in the United States. More patients are afflicted with oral cancer
than melanoma, cervical cancer, or ovarian cancer. Orofacial pain is one of the most common initial symptoms
of oral cancer and often leads to the diagnosis of oral cancer. However, the character, severity, and unique
features of oral cancer pain widely differ between patients. There is currently no effective and lasting treatment
available to alleviate suffering from oral cancer pain. Clinical and preclinical data suggest that cancer causes
pain through the secretion of mediators that activate and sensitize nociceptors; however, the specific
contributions of nociceptive mediators and their mechanisms of action (i.e., responsible receptors) are unknown.
The foundation for this proposal is based on preliminary studies demonstrating that oral cancer patients
experience preoperative sensitivity to capsaicin (i.e., chemosensitivity) and report greater functional (i.e.,
mechanosensitivity) pain. The outlined experiments will test the hypothesis that the quality of pain experienced
by oral cancer patients is dependent on the level of activation of specific channels on nociceptors. The overall
objectives of this proposal are to 1) develop and validate assays to quantify mechano- and chemosensitivity in
oral cancer patients, and compare the sensitivities to healthy subjects, and 2) determine the receptor subtypes
responsible for nociceptive behavior in an oral cancer mouse model. The knowledge gained from the proposed
research holds considerable promise for the development of novel, non-opioid treatment strategies that
specifically address the unique pain experienced by individual patients. Successful completion of the proposed
training plan will provide the candidate with the skills and experience necessary to direct an integrated clinical
and laboratory research program to address pain-related challenges in pediatric dental patients.

Public health relevance
PROJECT NARRATIVE Oral cancer is one of the most painful cancers, yet the etiology of oral cancer pain remains unknown. The proposed studies will characterize sensory changes and pain that accompany oral cancer in clinical and preclinical settings. Knowledge gained from the proposed research may facilitate the development of individualized pain therapies to specifically address pain in individual patients.